INTRAOPERATIVE HEMODYNAMIC STUDIES DURING HEART TRANSPLANTATION

The purpose of this study is to measure right and left heart pressures and flows (cardiac index) during the immediate perioperative period, before and after cardiopulmonary bypass of the surgical procedure and for the following seven consecutive postoperative days in order to assess hemodynamic characteristics of the right and left heart homograft.